Methylation changes, gene-environment interactions and the occurrence of Alzheimer's Disease: the AGES-RS Study

A recent advancement towards understanding the pathobiology of AD is the identification the role of the epigenome, an intermediary between genetic and environmental interactions that can contribute to the risk of complex disease. The epigenome modulates cell- and tissue-specific gene expression, and is also affected by nongenetic risk factors, smoking being a well-established modulator of the epigenome. Ultimately, the epigenome can change gene and protein expression, and vulnerability to disease.
This project will create a new and novel resource of DNA methylation data based on a deeply phenotyped longitudinal cohort, AGES-RS, of older men and women born 1914 to 1934. The sample to be included in this study will also have available whole genome sequencing data and a complete ascertainment of dementia cases.

This project started July, 2020. For each of 4000 AGES participants a bio-specimen was drawn from AGES1 and AGES2 which was collected 5 years after AGES1. All samples have been processed and normalized and data were sent to NIA via the Icelandic Heart Association. Hardware and software preparations to accommodate this large dataset are being and analyses will begin.